A novel role for developmental microglial-parvalbumin interneuron interactions in adult alcohol drinking behavior.

ABSTRACT
Alcohol use disorder (AUD) is a damaging and pervasive mental disorder that presents a large health and
socioeconomic burden globally. Strong risk factors for AUD include early life challenges that cause inflammation,
such as early life stress and early exposure to alcohol. Microglia, the brain’s resident immune cells, both respond
to inflammatory challenges and organize developing circuits, lending strong support to the theory that immune
signaling changes during development alter circuit maturation to increase later life drinking. Therefore, in my
proposal, I will determine if there is a developmental sensitive window for increased drinking vulnerability
controlled by microglia. My preliminary data suggests that microglia are responsible for increased adult alcohol
consumption through a developmental mechanism: loss of pro-inflammatory signaling specifically in microglia
through the ablation of MyD88, a critical toll-like receptor signaling molecule, increases voluntary adult drinking
in both acute and chronic drinking paradigms. Parvalbumin interneurons (PVIs), late-maturing critical regulators
of coordinated cell activity across the brain, are also altered in frontal cortex of MyD88-deficient mice, an effect
that is exacerbated by early-life inflammation. This PVI change points to a potential mechanism through which
microglia are impacting circuit maturation and behavior. Based on this, my central hypothesis is that MyD88-
deficient microglia improperly regulate the size of the developing PVI population through reduced phagocytosis,
leading to increased inhibitory frontal cortex activity in adulthood that drives excessive drinking. I propose to test
this hypothesis in two aims. In Aim 1, I will determine if MyD88-deficient microglia exhibit reduced phagocytosis
of PVI cells or synapses during development through immunohistochemical techniques. Then I will test the
hypothesis that loss of this function in the frontal cortex during a specific developmental window is sufficient to
induce the altered drinking behavior in adulthood. I will do this by administering a temporary microglial
phagocytosis blocking compound to the frontal cortex during development and then measure adult drinking. In
Aim 2, I will determine whether changes to frontal cortex PVI activity can drive increased adult drinking. Using a
Cre-dependent chemogenetic approach, I will deliver excitatory or inhibitory designer receptors exclusively
activated by designer drugs (DREADDs) to PVIs in the frontal cortex of adult mice, then deliver a designer drug
across the course of an acute drinking paradigm. This will uncover whether increasing or decreasing PVI activity
in the frontal cortex is driving the excessive drinking seen in MyD88-deficient animals. The proposed work will
have an important positive impact not only on our understanding of AUD and its risk factors, but also will answer
basic neurodevelopmental questions about the role of microglia in shaping inhibitory circuits and future behavior.
The outcome of this project will be specific targets, such as microglial inflammatory signaling and PVI function
in the frontal cortex, to manipulate in future studies to progress the prevention and treatment of AUD.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder is a destructive mental disorder that impacts nearly 15 million American adults, but many key risk factors point to developmental perturbations as important contributors to disease. My preliminary data point to a critical developmental role of microglia, the brain’s innate immune cells, and their impact on maturing parvalbumin GABAergic interneurons, in increased voluntary alcohol consumption in adulthood. This proposed study will answer both basic neurodevelopmental questions about microglial sculpting of inhibitory maturation in the frontal cortex and seek to identify a mechanism through which developmental microglial signaling changes influence excessive drinking behavior to improve our understanding of alcohol use disorders.